Nanofibrous self-gelling microspheres for heart regeneration

Nanofibrous self-gelling microspheres for heart regeneration
Cardiovascular disease (CVD) is the leading cause of death in the world today. In particular, myocardial
infarction (MI), commonly known as heart attack, results in permanent heart muscle damage or death, and is
the number one killer of heart patients. One major challenge to heart functional recovery after MI is the harsh
environment of infarcted areas, which prevents either repopulation of endogenous cells or/and
retention/integration of transplanted cells. We have developed injectable nanofibrous self-gelling microspheres
as a novel cell carrier and found they dramatically increase cell engraftment in infarcted hearts. We have also
developed novel technology for controlled release of biomolecules to enhance heart regeneration. In addition,
we have discovered that an epigenetic drug valproic acid (VPA) reduces ~50% of the infarct size when
administrated after ischemia reperfusion (IR) and preserves the pumping function of heart in a rat MI model.
We therefore hypothesize that high retention of transplanted cells and a reviving epigenetic microenvironment
for them can synergize cardiac muscle regeneration in infarcted heart, substantially improving functional
recovery. The following specific aims are proposed to test our hypothesis and develop novel regenerative heart
therapy: Aim 1. Determine the molecular mechanism of VPA in enhancing cell survival in infarcted heart. Aim 2.
Develop nanofibrous self-gelling microspheres as a carrier for cells and biomolecules. Aim 3. Regenerate
infarcted heart using VPA and cell-carrying nanofibrous self-gelling microspheres in immunodeficient rats. By
accomplishing these specific aims, we will achieve substantial new mechanistic understandings and will
develop novel and advanced technologies for heart regeneration.

Public health relevance
NARRATIVE Existing treatments for heart attack are primarily pharmacological and device-based, and do not address the fundamental problem of heart muscle cell loss. The proposed project integrates a biomimetic cell carrier for cell transplantation and a controlled release system for a repurposed small molecule epigenetic drug. This study will lead to new mechanistic understandings and novel and advanced technologies to protect the host heart cells and integrate transplanted cells for heart regeneration.